Analysis Core (Anc)

The goal of the Data and Analysis Core (AnC) of the proposed Alzheimer's-related Resource Center for Minority Aging
Research (AD-RCMAR), Mass-ENVISION, is to support RCMAR Scientists through consultation, guidance, and hands-
on support for the implementation of best data practices. In conducting the proposed Alzheimer disease and related
dementias (ADRD) research projects, RCMAR Scientists will need to rely on standard data collection and analysis tools as
well as develop new tools and innovate in the leveraging of novel, often technology-driven, tools. The AnC will provide
guidance on implementing best practices, and navigating the substantial expertise and resources available to RCMAR
Scientists through Mass-ENVISION affiliations with Massachusetts General Hospital, Brigham and Women’s Hospital,
Harvard Medical School, Boston University (BU) and BU School of Medicine, Cambridge Health Alliance, the
Massachusetts Alzheimer’s Disease Research Center (MADRC), BU-ADRC, Boston Claude O. Pepper Older Americans
Independence Center (OAIC), Hebrew SeniorLife, and more. The AnC will be led by Drs. Bettina Hoeppner and Benjamin
Cook, and will be supported by access to experienced statisticians, qualitative data experts and system engineers. Our team
builds on four key strengths: (1) deep mentoring experience across a diversity of research settings and topics, where our
AnC members have served as mentors on numerous NIH-funded career development awards (e.g., F32s, K01s, K23s, K12s);
(2) a focus on diverse and underrepresented in medicine (UiM) populations, for whom our AnC Co-Leads run behavioral
and social science research projects focusing on UiM, marginalized or stigmatized populations; (3) demonstrated investment
in pooling science-advancing resources and making them broadly available (e.g., PI of NIDA-funded R24 on advancing the
science on recovery community centers; PI of P50 ALACRITY Center); and (4) a shared dedication to dismantling structural
racism through mentorship of promising scientists from diverse backgrounds (e.g., UiM undergraduate student training
program, R13s). The specific aims of the AnC are to: 1) Provide (statistical, data analysis) mentoring to RCMAR Scientists;
2) Support unique and emerging measurement needs for RCMAR Scientists; 3) Provide guidance on mHealth data to
RCMAR Scientists; and 4) Curate existing and emerging data sources across Mass-ENVISION and AD-RCMARs. In
summary, the proposed Mass-ENVISION Data and Analysis Core will support RCMAR Scientists through consultation,
guidance, and hands-on support at key points during the progress of their projects. The AnC will guide RCMAR Scientists
in best data practices that will enable the rapid translation of their research findings into publications, promote their long-
term research career success, and facilitate the harmonization of data sources across RCMAR studies.